Developing a Service Planning Tool to Address the Combined HIV and Opioid Epidemics

Abstract
The complex relationship between HIV, HCV and opioid use disorder has resulted in an acceleration of several
inter-related public health emergencies that include new HIV and HCV infections and unparalleled overdose
deaths in the United States. Despite a number of evidence-based practices to address these inter-related
epidemics, they are often not adequately scaled to meet the unique needs of the specific community. While
evidence-based practices such as opioid agonist therapies, syringe services programs, pre-exposure
prophylaxis and antiretroviral therapy are core elements of an HIV prevention and response toolkit, these
interventions are often unavailable or under-scaled in many settings. Moreover, other evidence-based practices
like overdose education and naloxone distribution and direct-acting antiviral medications for HCV may not tackle
HIV related outcomes, but could influence opioid and HCV outcomes, respectively. Determining the scale of
each intervention within the constraints of a specific intervention allows a multi-pronged approach to addressing
overlapping conditions. Public health and policy experts need new and comprehensive tools to plan an effective
strategy to address inter-related risks for diseases that are often financed through different funding streams. Our
proposal aims to guide the public health and service planning to response to diverse epidemics. Specifically, this
project will: 1) Develop a cost-based epidemiological planning tool to identify the optimal portfolio of EBPs to
disrupt the adverse consequences of the HIV, HCV and OUD epidemics in the 50 states. The model will be
implemented as an interactive, web-based dashboard to assist policy makers in planning an effective response
and provide improved estimates of state-wide and local epidemic trajectories; 2) Conduct early usability and
feasibility testing of the dashboard by collaborating with a team of state and local public health officials in order
to optimize the future implementation of this dashboard. This portal will disseminate the epidemic model that can
be used by local public health experts to test the impact of various HIV and HCV rapid responses through
simulation. The proposed study may help guide a more efficient allocation of scarce resources to stem the HIV
epidemic and consequently improve health outcomes among PWID in a high-risk HIV setting. As part of this
exploratory R21, future directions will include assessing implementation strategies to improve use of the newly
developed dashboard to guide a public health response.

Public health relevance
PUBLIC HEALTH RELEVANCE: The project focuses on development of a planning tool that provides public access to an advanced epidemiological model in order to identify optimal portfolios of interventions to disrupt the adverse consequences of the HIV, HCV and Opioid Use Disorder epidemics among PWID in the 50 states. The project team will conduct usability and feasibility testing of the planning tool by collaborating with a team of state and local public health officials.